Core D. External Research Resources Support and Dissemination Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Core D – External Research Resources Support And Dissemination Core
The external research resources and dissemination core is responsible for communicating the findings of Center
research to a broad audience. Dissemination is done through the initial distribution of research findings in the
NBER working paper series, the preparation of non-technical articles and reports that appear in the NBER’s
newsletters, the posting of major findings on social media, and the maintenance of all research products and
resources on the NBER website. A notable product of the dissemination core is a targeted non-technical
newsletter of research findings: the NBER Bulletin on Health, produced as companion to the NBER’s general
newsletter series. Each issue focuses in depth on findings from three or four health-related studies that are
particularly important or noteworthy.